Automated Insulin Delivery for INpatients With DysGlycemia (AIDING)

PROJECT SUMMARY
More than 8 million people with diabetes are hospitalized each year in the United States.
Hospitalized patients with uncontrolled diabetes have a disproportionate risk for poor hospital
outcomes. Current strategies using multiple daily injections (MDI) of insulin often fail to improve
glycemic control. Recent trials have shown that adding continuous glucose monitoring (CGM) to
MDI may have a positive but modest impact on inpatient glycemic control. While high quality
European studies from a single research group have shown improvement in glycemic control
with automated insulin delivery (AID), several questions remain about reproducibility,
sustainability, dissemination, and scalability. First, the use of expensive insulin pumps with
tubing is not ideal for the hospital (potential infection transmission if used in multiple patients,
reduced mobility, and cost concerns); second, the role of hospital staff in the use of AID has not
been defined; third, methods for confirmation of CGM accuracy and electronic health records
(EHR) documentation are not established; fourth, remote insulin delivery and remote AID and
glucose monitoring has not been tested in the hospital (relevant for patients under isolation
precautions); fifth, there is a need for regimens for heterogenous populations usually excluded
from clinical trials (e.g. type 1 diabetes, steroid-induced diabetes). The Automated Insulin
Delivery in Inpatients with Dysglycemia (AIDING) trial, informed by a recently completed
feasibility pilot study, will address these questions in a multicenter randomized clinical trial (Aim
1). A heterogenous adult population with diabetes requiring insulin therapy will be randomly
assigned to AID with remote real-time CGM or to MDI plus CGM. Patients in the intervention
arm will wear a disposable single-user patch pump capable of remote insulin delivery. Sensor
glucose values will be documented in the EHR with periodic confirmation of accuracy and will be
monitored remotely by nursing staff and the study team to detect potentially dangerous
hypoglycemic or hyperglycemic episodes. The primary endpoint is time spent in target glucose
range (70-180 mg/dL). Safety will be assessed by time spent in hypoglycemia (<54mg/dL). In
Aim 2, we will conduct a mixed-methods evaluation (surveys and semi-structured interviews) to
examine additional infrastructure needs and factors that influence the adoption of inpatient AID
among end-users (i.e., study participants, nursing staff) and relevant hospital staff stakeholders.
This approach will facilitate the creation of standardized care and implementation algorithms to
facilitate sustainability and scalability of inpatient technology use to other health systems and at-
risk populations.

Public health relevance
PROJECT NARRATIVE Acutely ill patients with diabetes are often unable to maintain good glucose control in the hospital and are at risk of potentially devastating outcomes. The proposed project seeks to transform inpatient diabetes management through the implementation of automated insulin delivery (AID) utilizing a strategy that simultaneously addresses key safety elements surrounding in-hospital use of diabetes technology (i.e. use of disposable devices, nursing staff rapid response with alarms, electronic health records documentation, and remote monitoring of continuous glucose trends and insulin delivery rates). Findings from this project, including a randomized clinical trial and a detailed assessment of diabetes technology adoption, will inform the design of a larger study aimed at evaluating clinical outcomes and initiate a trajectory of research focused on the implementation of advanced diabetes technologies in the hospital.